Transcutaneous Phrenic Nerve Stimulation for Treating Opioid Overdose

Project Summary. This UG3/UH3 project is focused on the development of an
Automated External Respiratory Support (AERS) system intended to rescue people from
opioid-induced respiratory depression (OIRD). AERS is a portable electronic device that
can be deployed in the community, like an Automatic External Defibrillator (AED),
designed to be used by untrained individuals to maintain lifesaving ventilation by
stimulation of the phrenic nerve through small electrode patches on the neck until
definitive treatment can be provided or the overdose wears off.
Project Abstract. In the U.S., an exponential increase in opioid-related overdose deaths
has occurred over the last decade. The hallmark symptom of an opioid-related overdose
is decreased respiration, which can result in permanent hypoxic brain injury within
minutes. The purpose of the proposed research is to develop a community-deployable
Automated External Respiration System (AERS) device that is capable of maintaining
adequate respiration in individuals experiencing opioid-induced respiratory depression -
via external stimulation of the phrenic nerve - until other medical interventions (e.g.,
naloxone) can be administered or the effects of the opioids dissipate naturally over time.
The concept of the AERS device is modeled after Automated External Defibrillator
devices (AEDs), which are now widely available in medical and public settings for use by
both medically trained and untrained individuals.
A prototype AERS device was developed under a previous Small Business Innovation
Research grant awarded to Coridea and demonstrated to be safe and effective in
sustaining breathing in a preclinical model of drug-induced respiratory depression. The
proposed research seeks to qualify the prototype system for human use, demonstrate
feasibility and safety in human volunteers in a hospital setting, and then develop a
commercial system capable of community deployment. The current prototype will be
further optimized in miniature pigs (Aim 1a), and then evaluated for safety using rigorous
testing in pigs under fentanyl-induced respiratory depression with different levels of
chest wall compliance to mimic fentanyl-induced “wooden chest syndrome,” and finally in
the setting of naloxone reversal (Aim 1b). Results from Aims 1a and 1b will be used to
support an IDE for testing the AERS device in a clinical model of opioid-induced
respiratory depression in healthy volunteers without (Aim 2a) and with opioid use
disorder (Aim 2b). The prototype device will then be tested in a human factors study
(Aim 3). The data collected in Aims 1-3 will be submitted to the FDA for approval of a
pivotal trial (designed in collaboration with the FDA), which will be supported by a future
grant proposal.
The AERS device is built on the successful concept for treating cardiovascular
dysfunction and can potentially be used in combination with AEDs to treat multi-drug
overdoses (e.g., stimulants + opioids) and may offer a critical tool for use by medical and
lay persons to reduce the morbidity and mortality associated with opioid overdoses.

Public health relevance
The United States is in the middle of an opioid overdose epidemic. In this grant we will develop and validate an automated external respiration system, like a “respiratory AED”, that can provide life-saving therapy for people suffering from opioid-induced hypoventilation and apnea. This system can be deployed in public spaces and we believe that this therapy will significantly reduce the mortality and morbidity associated with opioid overdoses.